Core B: Bioinformatics and Biostatistics Core

Summary/Abstract
The Bioinformatics and Biostatistics Core is responsible for providing high-quality genomic and epigenomic data
analysis for the four research projects outlined in this Program, for developing infrastructure for cross-project
data sharing, and for identifying important biological processes involved in the initiation and progression of glioma
and medulloblastoma by integrating cross-project genomic data sets, and for comparing data from the Program
Project Grant with the extensive data resource generated from by other large-scale genomic projects including
St. Jude/Washington University Pediatric Cancer Genome Project (PCGP), The Encyclopedia of DNA Elements
(ENCODE) and The Cancer Genome Atlas Project (TCGA). Core B has access to state of art computing
infrastructure at the St. Jude High Performance Computing Facility (HPCF) as well as analytical tools,
computational pipeline and data management infrastructure established at the Department of Computational
Biology. Core B will be responsible for analyzing data generated from the Program Project including exome
sequencing, RNA-Seq, Ribo-seq, whole-genome bisulfite sequencing (WGBS), ChIP-Seq, Assay for
Transposase-Accessible Chromatin using sequencing (ATAC-Seq) and methylation array. We will apply the
most advanced public methods as well as novel methods developed by the Department of Computational Biology
or the Biostatistics Department. We will also provide biostatistical expertise for all projects.

Public health relevance
Core Narrative The Bioinformatics and Biostatistics Core (Core B) will provide expert computational analysis for genome, transcriptome, epigenome and proteome data generated and studied in the Program. The Core will also provide expert Biostatistical support for experimental design and interpretation. All Projects will be supported by this Core.